U2C/TL1 NC KUH TRIO Program

North Carolina is distinctly advantaged to be the home for a trio of well-established, premier academic medical
centers that already engage in collaborative and multi-institutional programs supported by world-class
researchers and mentors with internationally recognized expertise in kidney, urologic, and hematologic (KUH)
specialties. Our multi-institutional application also includes three top historically black colleges and universities
(HBCUs) in North Carolina that are all constituent institutions in the UNC 16-college system. Working with these
HBCUs enhances our ability to identify and mentor a diverse cohort of trainees and early career investigators
from high school through early faculty. We propose to develop discoverers who are representative of our diverse
KUH disease population through the North Carolina Kidney, Urology, and Hematology Training, Research,
Innovation, and Outreach Program (NC KUH TRIO Program), abbreviated as TRIO. The principal goal of TRIO
is to improve the care and outcomes for patients with KUH diseases, and we are proposing a comprehensive
roadmap that will train and mentor a multidisciplinary workforce, from engineers to entrepreneurs to physicians,
who will achieve this goal. A Training Core and linked Administrative, Networking, and Professional Development
Cores will function in concert to achieve the TRIO Specific Aims and provide a seamless experience for trainees
utilizing a platform that spans our institutions and cores. The Training Core will provide state-of-the-art training
for both pre- and post-doctoral trainees to prepare them for cutting-edge, collaborative, innovative and cross-
disciplinary research in KUH areas of interest. The Administrative Core supports TRIO to foster diverse,
integrated activities and address program goals. Through the Networking Core, TRIO will provide the
infrastructure to attract new talent from the biologic and physical science, retain students entering STEM
programs, and connect a broad and vibrant cohort of trainees. Finally, the Professional Development Core will
offer training that will expose trainees to multidisciplinary research, novel technologies, and professional
development opportunities to expand their scientific and clinical experience and in the end, accelerate KUH
research. With these Cores working in concert, TRIO is poised to grow and thrive in exciting ways as it trains a
diverse cohort of future KUH researchers, who will ultimately change the lives of patients with KUH diseases.

Public health relevance
Project narrative It is imperative to train researchers in clinical, scientific and technological areas to advance the fields of Kidney, Urology and Hematology (KUH) towards bringing better understanding and management to KUH conditions and diseases. This program in North Carolina combines expertise and novel concepts in Training, Research, Innovation, and Outreach to form the NC KUH TRIO Program, bringing together six institutions across the state; 3 academic medical centers and 3 historically black universities that have strong science, technology, and engineering programs. TRIO will support pre- and post-doctoral trainees, providing them with innovative research tools and a professional development foundation to launch KUH research careers.